Introducing Neuroscience and Neurocomputation Concepts to High School Students using Brain-based Neurorobots

PROJECT SUMMARY
Backyard Brains seeks a Technical and Business Assistance (TABA) supplement to
its SBIR Phase II project that is delivering the SpikerBot neurorobot and curriculum for
high-school neuroscience. This supplement will address final commercialization
barriers by (i) validating target customer segments through structured
Jobs-to-Be-Done interviews and comprehensive persona analytics, (ii) producing
professional-grade video, photography, persuasive campaign copy, and ad creatives
optimized specifically for a Kickstarter launch, and (iii) generating a robust, qualified
pre-launch audience list through precisely managed, data-driven media A/B testing.
All proposed activities will be executed by specialized external vendors during a
potential one-year no-cost extension period beginning 1 September 2025, or
compressed appropriately if no extension is granted. Success criteria include securing
at least $200,000 in Kickstarter pledges at a $399 unit price, compiling an email list of
8,000 validated leads, and publicly releasing polished, market-ready campaign
assets. No human-subject research or vertebrate animals are involved, and no
indirect costs are charged. These externally contracted activities are outside the
scope of the parent award and directly align with NIH SEED’s objective to translate
SBIR-funded innovations successfully to market.

Public health relevance
PROJECT NARRATIVE More than one billion people worldwide will experience a neurological disorder in their lifetime, yet most students leave high school with little understanding of how the brain works. The SpikerBot neurorobot gives teachers an affordable, hands-on tool to let students model brain circuits, see how neural activity drives behavior, and build skills that underlie modern neurotechnology and AI. By helping tomorrow’s workforce grasp core neuroscience concepts early, the project supports NIH’s mission to foster scientific literacy and accelerate innovations that improve nervous-system health.